UCLA Medical Genetics Training Program

PROJECT SUMMARY / ABSTRACT
The need to train the next generation of medical geneticists has never been more urgent. Our biggest challenge
in Medicine is to handle the flood of genomic information associated with new methodologies such as next
generation sequencing. The overwhelming power of these new technologies is transforming the traditional
approach to medical diagnosis and functional investigations. This renewal training proposal will prepare the
future generation to tackle a new reality in which: 1) genetic testing and technology continues to develop rapidly,
2) much clinical testing is done outside of the medical genetics clinic, either by other specialists or direct-to-
consumer, 3) there is a growing understanding of the influence of genetics on a vast array of human disease,
and 4) precision medicine based on genetic/genomic insights will transform the therapeutic landscape. Our
UCLA Medical Genetics Post-Doctoral Training Program utilizes the outstanding, diverse faculty and facilities of
the David Geffen School of Medicine at UCLA. The faculty of this program provides a wealth of research
opportunities, varying from basic molecular biology, genomics, cell biology, stem cell research, biochemical
genetics, cytogenetics, population genetics, to clinical genetics and dysmorphology. Our collaborative Faculty
will remain organized around three thematic areas: Genomic Medicine, Phenotyping in the Genomic Era, and
Treatment of Genetic Disease. Our current proposal includes 46 faculty members from 21 clinical and basic
science departments. These applicants and their mentors are united by a common goal: excellent scholarship
and leadership in human genetics research. We will provide our trainees with a broad knowledge of medical
genetics and an intensive experience in genetic research over a two-year period to prepare them to become
independent investigators, with a focus on linking basic science investigation in genetics to clinical medicine and
thus serve as future leaders. Major strengths of the training environment include a vibrant and growing clinical
genetics program with access to an ethnically varied population, state-of-the-art diagnostic laboratories in
cytogenetics, biochemical genetics, and molecular genetics, including a clinical genomics center that produces
exome sequencing, a wide variety of well-funded research laboratories, a longstanding training experience of
faculty, a specific postdoctoral course in medical genetics, an experienced associate director for diversity in order
to support the training of individuals from diverse backgrounds, including underrepresented minorities and
individuals with disabilities, who can enrich our program and the field of medical genetics. While our program
has a 33-year history of success, the changes implemented in the program are focused squarely on the training
of future leaders using the modern technologies of genomics, and enthusiastically embraces the enormous
changes that new discoveries will bring.

Public health relevance
PROJECT NARRATIVE Continuing advances in the facile generation of comprehensive analysis of individual genomes, transcriptomes and epigenomes has profoundly accelerated our ability to identify the genetic cause or rare diseases. With this transformative capability, there is a rapidly expanding need for expertise in genetics at the clinical, biochemical, cellular, molecular and informatics levels that are integrated into impact of individuals with rare and common diseases. This T32 training program will recruit and train young scientists and physicians to facilitate meaningful research into the causes, prevention and treatment of genetic diseases, become adaptable leaders in this rapidly evolving area of medicine.